Administrative Core - New therapeutic vulnerabilities in breast cancer

Project Summary/Abstract
The goal of the Administrative Core is to provide administrative support to the Program Project Grant, and to
actively promote synergy among projects and to facilitate the efficient use of the Cores. The Administrative Core
Administrator in the office of the Principal Investigator will be responsible for distributing the Program funds to
other participating Project and Core Leaders. In addition, the Administrative Core administrator will be
responsible for scheduling and organizing the monthly Program Project meetings and the annual Program
Retreats. This includes the scheduling of speakers for the monthly meetings and organizing overnight
accommodations, the logistics of meals, and agenda of scientific presentations from PPG and IAB (Internal
Advisory Board) member labs, as well as members of the EAB (External Advisory Board) for the annual retreat.
The Administrative Core administrator will also be responsible for communication with IEB and EAB members
including scheduling meetings and distributing material to be reviewed for these meetings as well as collecting
feedback and distributing honoraria to EAB members.